Repurposing Semaglutide for the Treatment of Cocaine Use Disorder: a Pilot Mechanistic Study

PROJECT SUMMARY
The United States is experiencing a resurgence in cocaine use and cocaine related mortality. In 2021,
approximately 1.4 million Americans met criteria for cocaine use disorder (CUD) with cocaine involved in nearly
25,000 overdose deaths, a 22% increase since 2020. No FDA-approved pharmacotherapies for CUD exist, and
traditional behavioral interventions such as cognitive-behavioral therapy (CBT) show modest treatment effects
when used alone. Identifying pharmacological interventions to enhance the effectiveness of behavioral therapies
remains a high priority area in NIDA’s Strategic Plan.
A highly promising class of pharmacotherapies for CUD treatment is glucagon-like peptide receptor
agonists (GLP-1RAs). These medications regulate blood glucose and facilitate other metabolic processes,
making them effective treatments for type 2 diabetes and obesity. Importantly, GLP-1Rs are expressed in many
brain regions, including the neural pathways associated with hedonic and reward-seeking behaviors. In animal
studies, GLP-1RAs reduce cocaine self-administration, locomotor stimulation, conditioned place preference,
and dopamine release in the nucleus accumbens. Clinical support for similar effects in humans would lead to
enhanced treatment outcomes either directly by reducing the motivational effects of cocaine and cocaine cues
and/or indirectly by enhancing response to therapies such as CBT.
The primary objective of this R01 Stage IIA study is to provide initial proof-of-concept evidence for
semaglutide, a GLP-1RA, as a treatment for CUD. We hypothesize that, mechanistically, semaglutide will
modulate three key reward-related target mechanisms underlying cocaine use: motivational relevance of
cocaine cues as measured by event-related potentials (ERPs); cocaine valuation as measured by behavioral
economic demand for cocaine; and the subjective experience of craving. We will conduct a multimodal
(neurophysiological, behavioral, self-report) assessment within the framework of a randomized clinical trial
comparing 14 weeks of once-weekly semaglutide versus placebo, as an adjunct to CBT, among persons seeking
treatment for CUD (N=75). In addition to modifying putative target mechanisms (Aim 1), semaglutide is
expected to reduce cocaine use (Aim 2), potentially correlated with changes in target mechanisms (Aim 3).
Beyond cocaine, we will explore off-target effects of semaglutide on alcohol, tobacco and marijuana
consumption (Aim 4), and utilize semaglutide’s titration schedule from 0.25 mg/week to 1 mg/week to explore
treatment effects at each level, toward identifying a minimal effective dose (Aim 5).
This project responds to the urgent call for testing novel medication targets through an experimental therapeutics
approach with the goal of identifying new purposes for approved medications. If successful, results will support a
fully-powered efficacy trial, potentially marking a major breakthrough in medication development for CUD.

Public health relevance
NARRATIVE No medications have yet been proven to be effective for the treatment of cocaine use disorder (CUD). Glucagon-like peptide 1 receptor agonists (GLP-1RAs), approved to treat type 2 diabetes and obesity, have recently emerged as highly promising candidates for medication repurposing, based on the expression of GLP- 1Rs in brain areas associated with hedonic and reward-seeking behaviors. This project represents the first clinical trial of a GLP-1RA (semaglutide) for CUD specifically designed to assess treatment effects on targeted reward-based mechanisms and cocaine use outcomes.